Mass Casualty Management System (DIORAMA-II)

DESCRIPTION (provided by applicant): The proposed DIORAMA-II system supports real-time assessment of a disaster site in terms of the victims' location and severity of injuries as well as the location of rescue personnel and resources. This application builds on a successfully completed R21 exploratory grant. The primary measurable outcomes of this system are: significant reduction in evacuation time of victims from the disaster site (average of 50% reduction in evacuation time compared to paper triage systems), 100% evacuation completeness of all triaged victims, and 100% geographical identification/verification of all triaged victims upon first responder triage. The first two outcomes correlate directly to reduced victims' mortality and the third is currently an unmet need in the disaster response discipline. The secondary outcomes are: enable the rescue personnel to treat the most critically injured victims first, improved response and management of medical rescue operations by assigning resources to the zones in most need, provision of seamless documentation of the rescue operations, enable post forensic analysis of the incident and rescue operations, provides data valuable to EMT training purposes, enable the hospitals to prepare for the arrival of patients, thus improving hospitals' utilization. This proposal is a joint collaboration between the University of Massachusetts, Amherst with an internationally team of leaders with recognized expertise in systems, software and hardware, Boston EMS which will provide the subject matter expertise and participate in our proposed trials, consultants such as the Director of the Division of Disaster Medicine at Beth Israel Deaconess Medical Center and a faculty member of Harvard Medical School, Medical Director of the Emergency Preparedness and Response Program at the Massachusetts Department of Public Health and the Massachusetts State EMS Medical Director, and advisory board which includes chief of Boston EMS that leads a 400-person department, president of the International Association of EMS Chiefs , the editor-in-chief of the Journal of Emergency Medical Services and also editorial director for all Elsevier Public Safety publications, former FEMA's Director of the Office of National Capital Region Coordination. We are confident that with the help of this internationally and nationally recognized team of leaders, innovative technology and very encouraging preliminary results obtained during the R21, we have very high chances of successfully completing these aims. This team of professionals will also advocate for the DIORAMA-II system to become a standard tool for disaster management.

Public health relevance
Project Narrative The proposed research is relevant to public health in being a unique tool that incorporates a most sophisticated use of modern information technology which can be of enormous help to those responsible for disaster management. Mitigating the impact of such incidents (e.g. flooding, terrorist attacks) is heavily dependent on adequate and timely flow of information and knowledge and the appropriate use of modern information technology to be able to, in real-time, seamlessly locate and track victims, rescue personnel and resources. This proposed system addresses the NIH mission to determine how best to utilize information technology in a disaster situation which poses a number of problems for which relevant informatics research is necessary. __SpecificAimsTextDelimiter__ Specific Aims The proposed DIORAMA-II system supports real-time assessment of a disaster site in terms of the victims' location and severity of injuries as well as the location of rescue personnel and resources. This application builds on a successfully completed R21 exploratory grant. The primary measurable outcomes of this system are: significant reduction in evacuation time of victims from the disaster site (average of 50% reduction in evacuation time compared to paper triage systems), 100% evacuation completeness of all triaged victims, and 100% geographical identification/verification of all triaged victims upon first responder triage. The first two outcomes correlate directly to reduced victims' mortality and third is currently an unmet need in the disaster response discipline. The secondary outcomes are: enable the rescue personnel to treat the most critically injured victims first, improved response and management of medical rescue operations by assigning resources to the zones in most need, provision of seamless documentation of the rescue operations, enable post forensic analysis of the incident and rescue operations, provides data valuable to EMT training purposes, enable the hospitals to prepare for the arrival of patients , thus improving hospitals' utilization. DIORAMA-II system obtains these outcomes by enabling real-time location and subsequent tracking of victims and emergency responders (paramedics, emergency medical technicians). The novelty of the approach includes the development of new algorithms that seamlessly mesh sensing and communication technologies such as RFID, GPS, Wi-Fi, cellular communication, and satellite communication as well as novel visual analytics techniques. The proposed system leverages the technology that we developed and successfully demonstrated under the funding of a R21 exploratory grant and that was recognized as a finalist in Vodafone Wireless innovation challenge. DIORAMA-II provides an information collection infrastructure that can be easily deployed, is scalable and is durable, allowing it to serve in the harsh conditions frequently seen in a disaster. It will aid in rapidly assessing the victims within a disaster scene, determine the response capabilities needed, and managing assets as they arrive and are utilized. This will enhance the effectiveness of the response in an ever-changing, often disorganized disaster. This is the first system to provide this functionality while preserving design guidelines such as easy to use technology, seamless integration in the first responders current triage and evacuation procedures, low cost technology which is scalable, i.e., can be deployed in any size disaster and is ruggedized to weather conditions. We propose the following specific aims: Specific Aim #1: Develop DIORAMA-II system: 1. Develop recurrent localization algorithm 2. Develop visual analytic tools 3. Develop automated forensic tool 4. Develop custom hardware Specific Aim #2: Testing and evaluation of DIORAMA-II in three phases. In the second and third phases we collaborate with Boston EMS. 1. Phase I : deploy and test the system in a closed known population in a confined area (a High School) 2. Phase II : deploy and test the system for Urban Search and Rescue operations 3. Phase III : deploy and test the system on more complex settings (Boston Marathon and 4th of July on the Boston Esplanade). Specific Aim #3: Dissemination of methods and trials' results will follow standard channels of peer-reviewed abstracts and publications as well as presentations in national forums of Emergency Medicine and Emergency Management conferences. We are confident that with the help of our nationally recognized team of leaders, innovative technology and very encouraging preliminary results obtained during the R21, we have very high chances of successfully completing these aims. This team of professionals will also advocate for the DIORAMA-II system to become a standard tool for disaster management.